Role of Y-family DNA polymerase Pol kappa in aging and Alzheimer's disease

Project Summary/Abstract
Genomic stability is critical for cellular function, however, postmitotic cells such as highly metabolically active
neurons face the biggest challenge as it must maintain its genome over organismal lifetime. DNA damage
increases with age and is accelerated in Alzheimer’s disease (AD) and multiple neurodegenerative disorders.
Hence specialized DNA polymerases have evolved to repair different DNA lesions that destabilize DNA helical
structure and obstruct replication and transcription. The Y-family polymerases are unique in bypassing DNA
damage and synthesizing DNA past specific lesions, thus recovering replication in dividing cells such as DNA
Pol kappa (Polk) that can bypass DNA lesions in both S and G0 phase. Surprisingly, we observed high levels
of Polk expression in non-dividing differentiated neuronal nuclei in the mice brain that mislocalizes to
lysosomes with age and in mice with AD associated transgenes. Almost nothing is known about Polk in
neurons and its role in the protracted aging process. Our long-term goal is to understand the role of Polk in
combating the DNA damages caused by cumulative exogenous and endogenous stressors, maintenance of
the central nervous system (CNS) genome and its relationship with AD. Here we will investigate Polk's role in
neuronal nuclei, and how mislocalization of Polk impacts neuronal maintenance during aging and in AD. This
will open a novel line of investigation of specialized Y-family DNA polymerases in age associated neuronal
disorders like Alzheimer’s.
Our central hypothesis is that Polk assists in multiple DNA damage response pathways to prevent genomic
instability and combat constant accumulation of DNA damage in post-mitotic neurons, where its expression is
critical in the neuronal nuclei. However, with aging and age-associated neuropathy decline in Polk's expression
in the nucleus and concomitant accumulation in the lysosomes results in neuronal genomic instability. We will
leverage our proteomics data to identify Polk associated proteins that work together as DNA damage response
to sustain neuronal genomic stability. Unbiased proteomics in neuronal nuclei will be performed to identify
novel Polk interactors. Overexpression of Polk in aging and AD genotype mice will investigate causal role of
Polk in neuronal genomic stability.
Specific Aim1 will test the hypothesis that Polk is associated with distinct DNA damage response
pathways in neurons and identify novel interactors of Polk
Specific Aim2 will test the hypothesis that recovering Polk's expression in neuronal nuclei can rescue
genomic stability in aging and AD neurons

Public health relevance
Project Narrative Alzheimer’s disease (AD) shows progressive histological and behavioral hallmarks correlated with increased genomic instability. We will study the role of Y-family DNA polymerase, Pol kappa (Polk) that can bypass unstable DNA lesions to maintain cell survival in post-mitotic neurons in healthy aging and AD genotype condition. Now immunostaining data provide compelling rationale that neuronal Polk nuclear expression is correlated with aging and AD, hence we will identify its associated repair pathways in neurons, establish Polk interactomes in neuronal nuclei and investigate Polk's protective role in maintaining neuronal genomic stability.